BMP-dependent pathways and Alzheimer's disease

SUMMARY
Amongst lipids that regulate intracellular transport routes, bis(monoacylglycerol)phosphate (BMP) is uniquely
located to multivesicular bodies (MVBs) and late endosomes/lysosomes (LE/Lys), where it controls intra-lumenal
vesicles (ILVs) formation. Upon fusion of MVBs with the membrane, ILVs will become exosomes. BMP thus
regulates the correct addressing of cargoes to recycling, lysosomal degradation or extracellular exosomal export.
Pathways regulated by BMP are profoundly altered in neurodegenerative diseases and levels of BMP are
modified in these disorders -e.g., in human autopsy brain samples of late onset Alzheimer’s disease (LOAD).
The ability to modulate BMP levels would open new perspectives in our understanding of the pathogenesis of
these disorders and could provide new therapeutic options. The key obstacle to this approach is that the enzymes
regulating BMP biosynthesis were so far unknown. Our lab recently identified an enzyme with phospholipase A2
(PLA2) activity -hereafter PLA2- regulating the limiting step of BMP synthesis in liposomes and in HeLa cell lines.
Here we propose that modulating PLA2 levels and accompanying BMP levels could be an attractive
strategy to modify pathological outcomes in LOAD. However, there is little that is known about PLA2 function
and localization in the brain. In Aim 1, we will test the existence of a direct link between PLA2 protein levels and
LOAD pathology in human autopsy brain samples. Specifically, we will use frozen samples from entorhinal
cortex, hippocampus, prefrontal cortex and cerebellum of patients with severe or mild LOAD and compare them
with unaffected control individuals. Using a combination of western blot and lipidomics, we will test (i) if protein
levels of PLA2 are modified in pathology-prone brain regions of LOAD patients compared to controls, (ii) if protein
levels of PLA2 correlate with disease progression and (iii) if BMP levels correlate with PLA2 levels. In Aim 2, we
will gather evidence pertaining to the most disease-relevant brain cell type and biological outcomes to target in
a future disease-modifying strategy. We will first identify the brain cell type localization of the PLA2 protein, using
co-staining for PLA2 and different cell type markers in control human autopsy brain samples sections, in wild-
type mouse brain sections and in microglia/astrocyte/neuron primary tri-cultures. In parallel, we will test whether
modifying PLA2 protein levels leads to altered endolysosomal function and affects LOAD-relevant outcomes
such as amyloid processing and exosomal release. We will down-regulate or overexpress Pla2 in mouse
microglia/astrocyte/neuron primary tri-cultures and test whether it affects BMP levels, amyloid production and
exosomal release, using a combination of confocal microscopy, western blot and Meso Scale Discovery (MSD)
assays. If successful, the proposed studies will enable us to establish a strong baseline of experimental
evidence on which we can build a robust disease-modifying strategy, to be investigated in a future larger
application.

Public health relevance
NARRATIVE Some lipids are key regulators of brain health and neurodegeneration due to their specific localization and function. One of these lipids has been known since the 1960’s, yet our lab only recently identified the protein that controls its levels. We propose to test the involvement of this protein in Alzheimer’s disease using patient samples and cell cultures derived from mouse models.